Discipline C: Radiochemistry, Analytical Track 2: Radiochemistry Capability/Capacity Development (Extension-Alpha)

Project Summary/Abstract ? Track2 The goal of this track of the project is to develop the necessary capabilities to analyze food samples for alpha-emitting radionuclides in addition to the existing capabilities to analyze for gamma-emitters. For this purpose, an alpha spectrometry system with 32 alpha chambers that has been donated to the Health Physics program will be serviced and placed back into operational condition. In addition, the necessary methods for sample digestion, radiochemical separation and source preparation will be tested and validated using standard reference materials. A Graduate Research Assistant will be trained to perform the required laboratory operations under the supervision of the laboratory director.